Controlling the Niche to Control Clonal Hematopoiesis

Over seven million people in the United States have acquired pathogenic mutations in their blood stem cells,
known as “clonal hematopoiesis” (CH), which increases their risk for life-shortening, strokes, heart and lung
disease and blood cancers. Expansion of the mutated stem cells is the root cause of these risks. While
inflammation and other hematopoietic stressors can favor the mutated blood stem cells, it is not exactly clear
why this is or how to block it. Much has been learned about how the cancer-causing mutations act in blood
forming cells but little is known about how mutated blood forming stem cells and their progeny reorganize the
local environment, or niche, in which they live. Our research has found that during periods of high blood cell
demand—such as infections, bleeding, or after myelosuppressive chemotherapy—the stem cell niche, “switches
on” to support stem cell expansion and increased blood cell production. Similar changes are present in CH-
affected marrow. Additionally, we've discovered signals that actively “switch off” the niche when the demand
for blood cells returns to normal, a process that fails in CH. The long-term goal of this research is to develop
new approaches to control niche activity, keeping healthy stem cells safe and making the environment
inhospitable for CH stem cells. The objective of this application is to define the mechanisms that switch the niche
on and off, with the aim of blocking these mechanisms to make life hard for CH stem cells. The central hypothesis
is that certain progeny of CH stem cells send signals to nearby blood vessel-lining cells in the niche to maintain
the niche in an “on” configuration. Targetable signaling pathways can reduce the expansion of CH stem cells in
the niche. We will complete two specific aims to test the hypothesis. Aim 1: Identify the upstream and
downstream mediators(s) that normally turn off the niche and why this doesn't happen in CH. Aim 2: Determine
the mechanism for turning on niche blood vessel-lining cells during stress in the presence of mutated cells. Both
aims are well supported by preliminary studies and use methodologies that have already been established to
be feasible. Our team has produced unique animal strains and models that allow, for the first time, genetic
dissection of these processes and have developed novel ex vivo models of the niche and innovative single-cell
sequencing technologies for molecular definition of the mechanisms at play. The research is innovative in its
focus on how mutated blood stem cells and their progeny affect the niche under different physiologic states,
challenging the view that niche functions are static and immutable. The significance of this work lies in
identifying the molecular mechanisms that give malignant stem cells a competitive advantage in the niche and
provides actionable therapeutic strategies to mitigate the risks for millions of people with CH.

Public health relevance
The proposed research is relevant to public health because identification of the mechanisms by which clonal hematopoiesis (CH) evolves is relevant to virtually all persons over the age of 50 years who harbor CH mutated stem cells and is also relevant to efforts to limit the cardiovascular complications of CH. This work is consistent with the NIH goal of fostering innovative research strategies for improving health, and with the NHLBI mission of supporting research that promotes the prevention and treatment of blood diseases, in this case, the currently non-modifiable risk from CH for adverse events and death. This work is also consistent with the NCI mission of supporting research to advance the treatment of cancer and the studies are responsive to the PA in presenting a discrete, specified, circumscribed project in an area of the investigators' specific interests and competencies, based on the mission of the NIH to enable the translation of basic discoveries into clinical practice research.